E-cigarette Inhalation and Cardiopulmonary Dysfunction

Abstract
The primary purpose of this Ruth L. Kirschstein NRSA F30 application is to provide the framework that will
prepare the applicant for a successful career as a physician scientist. Much of the applicant’s career development
will come from work in electronic cigarette (eCig) inhalation-induced cardiopulmonary dysfunction research, and
she will be provided the invaluable opportunity to carry out high quality research using a murine model of chronic
intermittent eCig vapor exposure. Cardiopulmonary diseases are the leading causes of death worldwide, and
cigarette smoking remains the most significant and preventable risk factor. While cigarette smoking prevalence
has steadily declined since 1950, there has been a recent drastic increase in the popularity of eCig or electronic
nicotine delivery systems (ENDS). Despite the perception that these products are “safer” alternatives to cigarette
smoking, recent cases of eCig or vaping product use-associated lung injury, denoted EVALI, demonstrate a
strong potential for harm. The impact of eCig on cardiopulmonary function has yet to be fully elucidated; however,
the applicant’s mentoring team demonstrated that chronic nicotine vapor inhalation alone induces activation of
the renin-angiotensin system (RAS) and pulmonary hypertension (PH) in mice. Furthermore, preliminary data
for this proposal indicate nicotine induces vascular dysfunction. While the previous study demonstrates that
nicotine has detrimental cardiopulmonary impacts, it is unknown if the addition of other eCig components (e.g.
propylene glycol/vegetable glycerin) will produce the same or greater harmful effects. Thus, investigation into
the possible synergistic activity of eCig additives with nicotine is warranted. The OBJECTIVE of this proposal is
to evaluate the effects of chronic eCig vapor inhalation on cardiopulmonary function, which could contribute to
EVALI, in a murine model of chronic eCig vapor inhalation. The proposed HYPOTHESIS is that chronic eCig
vapor inhalation disrupts RAS homeostasis, leading to vascular dysfunction, PH, and right ventricular
(RV) remodeling. The proposed study will employ a wide variety of state-of-the-art tools and techniques to test
the hypothesis using two specific aims: (1) Chronic eCig vapor inhalation promotes vascular dysfunction, PH,
and RV remodeling, and (2) Mechanisms of chronic eCig vapor inhalation-induced cardiopulmonary dysfunction
depend on RAS activation and angiotensin signaling mediated by the angiotensin type I receptor (AT1R). In
addition, this study will investigate if blocking angiotensin receptor signaling with Losartan will protect against
eCig vapor inhalation-induced cardiopulmonary dysfunction. Findings from this study will advance our
understanding of the detrimental effects of eCig on the cardiopulmonary system and may identify novel
therapeutic targets for the treatment of eCig related cardiovascular and pulmonary diseases (CVPD). With the
support of a strong multidisciplinary mentoring team, completion of the proposed training plan will ensure that
the applicant is ready to embark on a career in academic medicine.

Public health relevance
Narrative This NRSA F30 fellowship will provide an invaluable training opportunity for a future physician scientist as she develops into an emerging leader in cardiovascular and pulmonary disease related research. The proposed studies will investigate the impact of chronic e-cigarette vapor inhalation on cardiopulmonary function and explore the efficacy of an antihypertensive drug, losartan, in preventing any detrimental effects. Findings from this study will further our understanding of the negative consequences of e-cigarettes and may identify novel therapeutic targets for the treatment of e-cigarette related cardiopulmonary dysfunction.